Effect of Prosthetic Foot-Ankle Stiffness on Standing and Walking Performance in Transfemoral Prosthesis Users

The anatomical foot and ankle joint provide important functions during gait, so fitting lower-limb prosthesis users
with components that replicate these functions is rational and desirable. However, it is not currently known how
to best combine and tune prosthetic foot and ankle stiffness to enhance a prosthesis user’s walking and standing
performance simultaneously. Furthermore, altering prosthetic foot-ankle stiffness could adversely affect
prosthetic knee stability in transfemoral prosthesis users. Therefore, we propose to systematically vary the
stiffness of the prosthetic foot and ankle joint combination in transfemoral prosthesis users to help establish
prescription guidelines for prosthetists to consider when fitting prosthetic ankle units with prosthetic feet. The
Veterans Health Administration (VHA) reported that between 1989-1998, 29% of amputations were performed
at the transfemoral level. This emphasizes the strong relevance and potentially high impact of this research study
on current Veterans, which is directly applicable to the VHA’s Patient Care Mission.

Public health relevance
Fitting lower-limb prosthesis users with prosthetic foot-ankle mechanisms that attempt to replicate corresponding anatomical functions is desirable (Hansen et al., 2004a,b, 2007, 2010). Our laboratory previously demonstrated that prosthetic ankle joints improve walking performance in groups of individuals with transtibial amputation (Su et al, 2007; Su et al., 2008; Su et al., 2010) and transfemoral amputation (McNealy & Gard, 2008). However, while research subjects indicated a preference for walking with the prosthetic ankle components, several stated that they felt unstable during standing. Furthermore, the increased motion provided by the ankle components significantly reduced the radius of the ankle-foot roll-over shape (Gard et al., 2011), which could adversely affect standing stability and gait performance (Gard & Childress, 2001; Klodd et al., 2010a,b), particularly in transfemoral prosthesis users. The purpose of this investigation is to determine how systematically varying the prosthetic foot keel stiffness and prosthetic ankle joint stiffness affects standing and walking in persons with unilateral, transfemoral amputations. Specifically, we will identify and weigh the different benefits and consequences of combining stiffer prosthetic footplates with more compliant ankle dorsiflexion bumpers, and vice versa, to determine how to best serve the needs of the prosthesis user and produce the greatest impact on gait and standing performance. Therefore, our specific aims and hypotheses for this project are: Aim 1: To perform mechanical testing of the prosthetic foot keels, ankle dorsiflexion bumpers and their combinations to characterize their stiffness, damping and energy storage/return properties. Force and displacement data will be acquired using an Instron materials testing machine. Aim 2: To determine the effect of different prosthetic foot and ankle stiffness combinations on gait biomechanics of unilateral, transfemoral prosthesis users. Kinematic and kinetic data will be collected as subjects walk at different speeds and with different combinations of prosthetic foot and ankle stiffness. We hypothesize that the prosthetic foot and ankle stiffness combination that best replicates the foot-ankle roll-over shape characteristics of the subject’s sound leg during walking will serve to (1) stabilize the prosthetic knee joint during early loading response phase, and (2) facilitate knee break during preswing, as evidenced by the prosthetic knee moments during stance phase. Aim 3: To determine the effect of different combinations of prosthetic foot and ankle stiffness on standing stability of unilateral, transfemoral prosthesis users. Standing balance of subjects will be evaluated during quiet standing and using a series of tests that measure balance and recovery stability as balance is perturbed. We hypothesize that subjects will have less sway and better performance scores on the balance assessment tests when fitted with stiffer prosthetic foot-ankle stiffness configurations, and sway will increase and performance scores will be reduced as the stiffness is decreased. Subjects will also be administered questionnaires to document their perceptions of comfort, exertion and stability while using the different prosthetic foot-ankle configurations. Increased understanding about how different prosthetic foot-ankle stiffness combinations affect standing and walking abilities will facilitate appropriate component selection by prosthetists, encourage development of prosthetic foot-ankle mechanisms with adaptable stiffness, and ultimately improve quality of life for prosthesis users.